The impact of amygdala CGRP receptors on the development of persistent bladder pain.

PROJECT SUMMARY
Urologic chronic pelvic pain syndrome (UCPPS) affects millions of individuals worldwide, and current
treatments are limited due to their lack of efficacy. Although the underlying mechanisms of the development
and maintenance of visceral pain are poorly understood, visceral pain is thought to engage brain circuits that
may contribute to chronicity. The central nucleus of the amygdala (CeA) has received increasing attention as a
significant region in the pathology of chronic pain. Findings from both human and rodent studies have revealed
hemispheric lateralization of the CeA in pain modulation. While the right CeA has been shown to drive pain in
models of somatic and visceral pain, the left CeA has been shown to attenuate visceral bladder pain. Recent
evidence has implicated that CeA neuronal activity is not only asymmetric, but also changes with time once
neuropathic pain is induced. However, it is unknown whether time-dependent activation of the CeA is prevalent
in persistent bladder pain. I aim to further explore the hemispheric and temporal changes of the CeA in the
context of bladder sensitization and injury, as well as identify cell-types that might be responsible for driving
these changes. Calcitonin gene-related peptide (CGRP) is a neuropeptide that has been shown to produce
divergent asymmetric functions within the CeA. In somatic pain, CGRP has been shown to have an
antinociceptive function in the left CeA and a pronociceptive function in the right. However, little is understood
about the role of CGRP and CGRP receptors in the brain in models of bladder pain. The overall objective of
this proposal is to determine the influence of CGRP receptors on bladder pain-related lateralization over time. I
will approach this goal by: 1) determining how CGRP receptor positive neurons (located in the right or left CeA)
may influence pain-like behavior in two persistent bladder pain models, and 2) studying CeA activity of CGRP
projection cells from the left or right parabrachial nucleus (PBn) in awake-behaving mice. Focusing on the
contributions of CGRP receptors in visceral pain modulation could provide insight into the underlying
mechanisms contributing to pain-related lateralization within the CeA. This, in turn, will lead to the development
and advancement of effective CNS targeted therapies for bladder pain.

Public health relevance
PROJECT NARRATIVE In the chronic state of bladder pain, central nervous system mechanisms likely contribute to on-going pathology. One area of likely dysfunction is the amygdala where differences between the right and left amygdala may alter the development of persistent visceral pain. This proposal seeks to determine the cell-type specific mechanisms that contribute to amygdala dysfunction and may prolong bladder pain after injury.